Developing a Structurally-Motivated Model of Coronary Microcirculation Mechanics and Hemodynamics

Project Summary
The myocardium relies on a continuous supply of oxygen from a complex system of blood vessels that make
up the coronary circulation. Despite its importance, the coronary circulation and how its flow is regulated are
not fully understood. To facilitate insights into the functioning of this complex physiological system, various
computational models have been developed to study a variety of characteristics of coronary flow, providing a
unique framework to integrate physiological and mechanical processes across different scales. The study of
coronary flow requires detailed knowledge of its network structure, from the large epicardial vessels, down to
the capillaries, and across the myocardium (from the epicardium to the endocardium). Most studies thus far
have relied on direct morphometric characterization of the larger coronary arteries (e.g., Kassab’s studies on
swine heart’s from nearly two decades ago), and on physics-based assumptions to generate volume-filling
microvascular networks. However, the structural design of the coronary microvasculature is non-trivial with
numerous elements influencing its form. Imaging the three-dimensional (3D) organization of the coronary
microvasculature with modern imaging techniques can facilitate insights into its function, structure, and
pathophysiology. In this proposal, I aim to conduct high-resolution imaging of a swine heart to perform
quantitative analysis of its coronary vascular morphometry across spatial scales. In Aim 1, I will define a tissue
clearing and vascular imaging protocol. To achieve this, I will optimize optical tissue clearing techniques to
render myocardial tissue homogeneously transparent using tailored treatments with hydrophilic chemical
cocktails (i.e. CUBIC reagents) for tissue delipidation, decoloring, and refractive index matching in combination
with fluorescent labeling of endothelial cells with tomato lectin and casting of the vasculature with dextrin-
rhodamine. Optimization of our approach will be accomplished in mice hearts, facilitating iterations, guiding its
application to larger swine hearts. Sub-micron vascular details will be captured over large tissue volumes using
episcopic techniques with a laser scanning confocal microscopy. In Aim 2, I will characterize the network
structure of the coronary microvasculature and identify adaptations in the setting of obesity. In order to study
the network structure, I will develop methods to segment the vasculature by creating toolkits that correct for
image artifacts, filter to enhance vessel-like structures, binarize and segment vessels, perform skeletonization
to preserve network topology, and merge vessel graphs. Custom analyses will be performed on merged vessel
graphs to quantify its morphology and topology. Using a clinically relevant metabolic syndrome model in
Ossabaw swine, I will then compare the microvasculature among lean and obese swine for quantitative
differences in morphology and topology. Successful completion of the proposed aims will provide critical insight
into the role of structural adaptations of the coronary microcirculation in disease states such as obesity and will
propel further coronary flow modeling by providing detailed anatomic data of the coronary microvasculature.

Public health relevance
Administrative Supplement - Disentangling the Mechanisms of Coronary Blood Flow Regulation through Multi-scale Modeling In this project, we request support for a post-doctoral candidate with a diverse background and from an underrepresented group in the biomedical research workforce who has a proven research track record and who demonstrates an enthusiasm for innovative ideas and tackling complex cardiovascular research questions. The scientific goals of the proposed project are to develop custom tissue clearing, microscopy imaging, and vessel reconstruction techniques to characterize the structure of the coronary microcirculation in healthy and disease states. The image-based networks obtained through this supplement will increase the relevance of the computational models of the parent R01.